Innate lymphocyte responses to early-life infections

Project Summary
Staphylococcus bacteria are the primary cause of healthcare-associated infections in neonatal intensive
care units and the leading cause of skin and soft tissue infections worldwide. In addition to causing impetigo, the
most common bacterial infection in children, Staphylococcus can result in life-threatening conditions, including
sepsis and Staphylococcal scalded skin syndrome. However, there are currently no effective vaccines available
for Staphylococcus bacteria, preventing maternal immunization, and the emergence of antibiotic resistance
impedes standard treatments. Consequently, there is a need to understand how the immune system responds
to Staphylococcal infections in early life. While innate immune cells utilize germline-encoded receptors to detect
conserved pathogen-associated molecular patterns, adaptive cells recombine receptor genes to generate a
broad range of antigen specificities, which delays the emergence of adaptive immunity. Following development,
adaptive immune cells require antigen-mediated activation within secondary lymphoid organs to express the
chemokine receptors and integrins necessary for tissue homing and produce effector cytokines or antibodies.
Consequently, adaptive immune cells are largely absent from most barrier tissues in early life, which instead
harbor innate lymphoid cells (ILCs) and innate-like T cells. Both primarily localize to tissues and rapidly release
cytokines due to their developmental acquisition of effector characteristics. While ILCs lack recombined antigen
receptors, innate-like T cells express semi-invariant T cell receptors that limit their antigenic range analogously
to innate immune receptors. Though these lymphocytes arise prior to the establishment of immunologic memory
and are abundant in early life, their contributions to immunity during this period remain poorly understood. The
primary goal of this proposal is to determine the role of innate and innate-like lymphocytes in early-life immunity,
which will be accomplished by 1) developing early-life murine infection models, 2) establishing the contributions
of murine innate and innate-like lymphocytes in these models, and 3) assessing the in vivo responses of human
innate and innate-like lymphocytes utilizing humanized mice. Combining state-of-the-art approaches from
immunology, genetics, and bioinformatics, this highly innovative project will further our understanding of early-
life immunity and lead to the development of novel therapeutics.

Public health relevance
Project Narrative Staphylococcus bacteria are the primary cause of healthcare-associated infections in neonatal intensive care units and the leading cause of skin and soft tissue infections worldwide, necessitating novel treatments that enhance early-life immunity. Although innate lymphoid cells and innate-like T cells comprise a substantial effector population in neonatal tissues, their contributions to immunity during this period remain poorly understood. Combining state-of-the-art approaches from immunology, genetics, and bioinformatics, this project will further our understanding of early-life immunity and lead to the development of novel therapeutics.